The role of O-GlcNAcylation in DNA damage repair and cancer therapy

Project Summary/Abstract
O-linked N-acetyglucosaminylation (O-GlcNAcylation) is a reversible posttranslational modification that
plays a key role in ionizing radiation (IR)-induced DNA damage response. O-GlcNAcylation is catalyzed by O-
GlcNActransferase (OGT), which transfers N-acetyl-D-glucosamine from UDP-GlcNAc to serine or threonine
residues of proteins. This posttranslational modification is also removed by O-GlcNAcase (OGA). In our
studies, we have shown that O-GlcNAcylation is significantly enriched at DNA lesions. Since the acceptors of
O-GlcNAcylation are serine or threonine residues, O-GlcNAcylation competes with DNA damage-induced
phosphorylation, which in turn regulates DNA damage repair. Thus, we hypothesize that O-GlcNAcylation is a
key molecular event in response to IR treatment, and targeting O-GlcNAcylation can be an effective
therapeutic strategy to cancer treatment.
In this research proposal, we plan to focus on one major O-GlcNAcylation substrate MDC1, and examine
the role of O-GlcNAcylated MDC1 in DNA damage response including the phosphorylation events on MDC1,
MDC1 governed protein ubiquitination cascade, and DNA double-strand break repair. Using O-GlcNAcylated
MDC1 as the readouts, we will analyze the biological functions of both OGT and OGA in IR-induced DNA
damage repair, and explore the inhibition of OGA as a novel therapeutic strategy to treat BRCA1 or BRCA2-
deficient tumors in vivo.

Public health relevance
Project Narrative O-GlcNAcylation is a unique posttranslational modification and plays a key role in repair of ionizing radiation-induced DNA double-strand breaks. In our preliminary study, we have shown that O-GlcNAcylation is remarkably enriched at DNA lesions and competes with DNA damage-induced phosphorylation events. In this application, we plan to examine the detailed molecular mechanism of O-GlcNAcylation in DNA damage response with focusing on “writer” and “eraser” enzymes, which may generate impact for future cancer therapy.